Post-transcriptional regulation of hepatokines and systemic metabolism

ABSTRACT
Nutrient availability affects many cellular processes that are important for health and disease,
including metabolic diseases such as diabetes, obesity, fatty liver and cardiovascular disease.
The liver is the central hub of metabolism and is intricately involved in coordinating and
maintaining metabolic health. The liver coordinates systemic metabolism is via secreted peptides,
or hepatokines, which enter the circulation and can trigger responses in a number of distal tissues.
There are well established transcriptional mechanisms that control hepatokine production, such
as the PPAR-dependent transcriptional regulation of FGF21, a hepatokine that controls energy
balance. Here we describe a novel mechanism by which the liver controls maintains homeostasis
in the fasted state, via post-transcriptional control of mRNA stability by a family of RNA binding
proteins (RBPs). Using global unbiased RNA-Seq analysis, we have identified a key hepatokine
as a specific target of the RBP family. We then show that hepatic loss of these RBPs results in
pronounced increases in the levels of mRNA as well as increased circulating levels of the
hepatokine. We have generated extensive metabolic analysis showing that loss of all three
members of the RBP family in the liver dramatically impacts body weight and energy balance. We
also generated an inducible knockout mouse model where the RBPs and the hepatokine are
deleted in hepatocytes, demonstrating that the hepatokine plays a significant role in the metabolic
regulation of the RBPs. In Specific Aim 1, we will test the hypothesis that the RBPs regulate the
hepatokine in the context of fasting, where they limit the surge in expression for the hepatokine
in the fasted state. Then, using a complementary gain-of-function model for one of the redundant
RBPs, we will use an inducible RBP overexpression model to identify direct RBP targets in the
liver. In Specific Aim 2, we have identified a second hepatokine that is also regulated by our family
of RBPs. We will determine the relative contribution of this hepatokine to the systemic changes in
metabolism we observe following liver-specific loss of RBPs. Lastly, we have identified human
variants in the 3’UTRs of both hepatokines, and will test whether these variants affect mRNA
stability and contribute to human GWA loci for metabolic traits. Our studies will provide a novel
layer of control for hepatokines and aid our understanding for how the liver regulates systemic
metabolism, which may open up novel therapeutic avenues to modulate and treat metabolic
disease.

Public health relevance
Relevance to Public Health Cardiometabolic diseases, including obesity, diabetes, and cardiovascular disease (CVD), are leading cause of death in the United States, which therefore represents a significant burden to the national health system. We have uncovered a novel layer of post-transcriptional regulation for key metabolic genes, which will advance our understanding of how our body maintains systemic metabolism and may result in improved therapeutic interventions.